Elucidating the role of microglial Beta-hexosaminidase in microglial regulation of perineuronal nets in homeostasis and Alzheimer's disease

Project Summary
The progressive cognitive decline observed in Alzheimer's Disease (AD) is linked to synaptic dysfunction and
the degradation of perineuronal nets (PNNs), which are critical for neuronal protection, synaptic stability, and
plasticity. Interestingly, the role of microglia, the central nervous system's resident immune cells, extends
beyond their well-known involvement in neuroinflammation to include the maintenance of PNN integrity.
Recent findings from our lab have revealed that β-hexosaminidase, a crucial lysosomal enzyme, is exclusively
expressed in and secreted by microglia. β-hexosaminidase is critical in maintaining normal neuronal function
and may also be involved in the regulation of PNNs. This research proposal aims to dissect the functional
implications of microglial β-hexosaminidase on PNN regulation under normal and AD-associated conditions. In
the first aim, we will explore the role of β-hexosaminidase in homeostatic PNN regulation by modulating its
levels in the mouse brain. Through a combination of enzyme inhibition, microglial cell replacement, and
recombinant protein infusion strategies, we aim to delineate the contribution of β-hexosaminidase to normal
PNN architecture. The second aim is designed to investigate whether β-hexosaminidase is implicated in the
early-stage loss of PNNs and gene expression changes in parvalbumin-positive neurons preceding their loss,
both hallmarks of AD pathology. By employing a mouse model of Alzheimer's disease (5xFAD) and replacing
native microglia with β-hexosaminidase-deficient myeloid cells, we will assess the impact of diminished β-
hexosaminidase activity on PNN preservation and neuronal health during disease progression. Given its
unique position at the nexus of microglial function and neuronal health, β-hexosaminidase represents a novel
therapeutic target whose manipulation could offer significant benefits in AD. This project will advance our
understanding of neurodegenerative disease research by highlighting the therapeutic potential of targeting
microglial enzymes for the preservation of critical neuronal structures. Through innovative methodological
approaches and a focus on the complex role of microglia in neurodegeneration, this proposal aims to bridge
significant knowledge gaps and offer novel insights into the mechanisms of AD pathology. Ultimately, the
findings from this study could broaden our understanding of the complex interplay between microglia, neurons,
and the extracellular matrix in the brain, paving the way for the development of new glia-targeted therapies and
expanding our repertoire of potential interventions in AD.

Public health relevance
Project Narrative Certain types of neurons, many of which are important for memory, are surrounded by specialized structures which protect them from toxic stressors and help stabilize their connections to other neurons. These structures decrease in Alzheimer’s disease, which may leave the neurons more vulnerable and therefore more likely to die. This project will improve our understanding of the means by which these structures are regulated in the healthy brain and lost in disease.